Biological Validation of Candidate Myeloma Driver Genes

Project Summary
Unprecedented progress in our ability to elucidate genetic changes in multiple myeloma (MM) has led to long
lists of candidate driver genes that are urgently awaiting biological validation – not only to enhance our
understanding of the natural history and genetic underpinnings of MM, but also to prioritize molecular targets
for new myeloma therapies and preventions. We will employ a newly developed, comprehensive preclinical
research strategy to evaluate in-depth a candidate myeloma driver that appears to be very promising from a
translational point of view: the forkhead box M1 transcription factor, FOXM1.
The long-term goal of this research is to improve the outcome of myeloma and related plasma cell
neoplasms. The main objective is to elucidate the mechanism by which putative myeloma drivers, such as
FOXM1, promote tumor development, acquisition of drug resistance and relapse with refractory disease. The
central hypothesis is that myeloma drivers increase the tumorigenicity, clonogenicity and therapy resistance
of malignant plasma cells and, therefore, provide a rational molecular target for new approaches to myeloma
treatment and prevention. Three Specific Research Aims have been designed to test this hypothesis and
achieve the objective of this application.
The studies in Aim 1 will evaluate the role of FOXM1 in myeloma biology and genetics. The
experimental strategy includes the evaluation of drug responses in myeloma cells containing elevated levels of
FOXM1 and clinical studies on FOXM1-dependent tumor progression. The anticipated outcome includes
evidence that FOXM1 is a worthy target of new treatment approaches that include repurposed FDA-approved
drugs. The studies in Aim 2 will determine whether FOXM1 drives neoplastic plasma cell development in
laboratory mice. The experimental strategy relies on the determination of tumor incidence and onset in mice
reconstituted with transgenic B-lymphocytes that harbor elevated levels of FOXM1. Also included are FOXM1-
targeted treatment studies using tumor -bearing mice. The anticipated outcome includes support for the
contention that FOXM1 promotes myeloma development and determines, in part, the drug response of
myeloma cells. The studies in Aim 3 will assess the genetic network of FOXM1 in myeloma. The
experimental strategy involves the determination of FOXM1-dependent gene expression changes in myeloma
cells and the mapping of FOXM1 binding sites in the myeloma genome. The anticipated outcome includes
increased network-based understanding of the mechanism by which FOXM1 promotes neoplastic plasma cell
development.
Supported by strong preliminary results that provide a sound rationale for this application, the proposed
research is poised to facilitate novel targeted approaches to the therapy and prevention of multiple myeloma.

Public health relevance
Project Narrative Plasma-cell myeloma, better known as multiple myeloma, is a common, difficult-to-treat and, in the great majority of cases, incurable hematologic malignancy. The research proposed here will validate candidate myeloma driver genes to facilitate the design and testing of targeted approaches to the treatment and prevention of myeloma.